Translational Research in Pediatric and Obstetric Pharmacology and Therapeutics

Project summary:
Preeclampsia is a leading complication of pregnancy, causing significant perinatal mortality and morbidity. It
remains a major medical challenge: its cause is still unclear, and there is no effective therapy. As a result, current
standards of care are highly resource-intensive and largely reliant on pragmatic measures including assessment
of known risk factors and close monitoring of blood pressure, urinary protein, ultrasound and the fetus. Once
diagnosed, patients receive symptomatic treatment including anti-hypertensives and anti-convulsants, which do
not address disease mechanisms or progression. Delivery, often premature, is the only “cure”. Although a
majority of preeclampsia complications occur in developing regions of the world, and there has been a steady
decline of maternal mortality in most developed nations, maternal mortality in the United States has actually
increased since 1990. A central problem is the lack of an effective, targeted therapy that addresses disease
pathogenesis. The previous lack of understanding of the disease and safety concerns have hindered
development of therapeutic agents, but recent discoveries have made this feasible. It is now understood that in
women who are developing preeclampsia, the stressed placenta releases “toxic, circulating” anti-angiogenic
proteins into mother's blood, scavenging vascular growth factors and damaging the vasculature. Preclinical and
clinical evidence indicates that it is feasible to reduce concentrations of anti-angiogenic proteins in the circulation,
and thus to reduce the severity of preeclampsia.
To translate this important knowledge into practical treatments, we have established relevant phenotypic
trophoblast models and screened 360 approved clinical drugs that have favorable safety profiles in pregnancy.
This pilot work has resulted in identification of promising drug candidates that show therapeutic potential for
preeclampsia, reducing release of anti-angiogenic factors from the placenta. In the present work, we will further
validate the efficacy, pharmacology, and pharmacokinetics of these agents in relevant trophoblast and animal
models of preeclampsia, with the goal of developing translational pharmacodynamic-pharmacokinetic data
bridging to known human dose exposures. We will also investigate the mechanisms underlying the new drug
effects. At the end of this study, we will select one best candidate, that has the most favorable pharmacologic
and safety profiles, for a future clinical trial in patients with severe preeclampsia.
Our innovative repurposing strategy, by selecting clinical drugs with favorable safety features for pregnancy,
circumvents the drawbacks of lengthy, costly, and high-risk conventional drug development, promising to
translate important science into clinical use in an efficient way. The outcome of this work will immediately support
a clinical trial in high-risk patients. If successful, we expect a fundamental impact on patient care, reducing the
health and socioeconomic burdens globally.

Public health relevance
Project Narrative Preeclampsia is a life-threatening condition in pregnancy that exacts a high toll on mothers and children. Its cause is still unclear, and currently there are no effective therapies because available medications do not tackle the core disease mechanism(s). The development of new medications is difficult due to safety concerns in pregnancy. Recent scientific discoveries have shed new light on mechanisms for preeclampsia, allowing us to test several hundred drugs, already known to be safe in pregnancy, and to identify candidates that may slow or stop the disease. In the work now proposed, we will characterize the most promising candidate drugs in detail to understand their actions, using cultured placental cells and animal models to mimic human preeclampsia. Our aim is to identify the best candidate drug to test in a future clinical trial in women with severe preeclampsia.